Targeting Tumor-Driven Immune Tolerance to Overcome Resistance to Hedgehog Inhibition

SUMMARY
Patients with basal cell nevus syndrome (BCNS) typically develop hundreds of basal cell carcinomas (BCCs)
due to germline mutations that drive aberrant activation of the Hedgehog (Hh) signaling pathway. Affected
individuals develop tumors even in early childhood and are at substantially increased risk of other potentially
fatal malignancies such as medulloblastomas and rhabdomyosarcomas. Although Hh-targeted therapies using
Smoothened (SMO) inhibitors are effective, their clinical utility is often limited by clinical resistance and tumor
recurrence. Cemiplimab, a PD-1 blocking antibody approved for BCCs refractory to Hh inhibitors (HHi), also
shows limited efficacy, with many patients experiencing disease progression. At present, there are no effective
treatments for HHi-resistant BCCs. Given that many advanced BCCs are refractory to or recur after treatment
with HHi, new intervention strategies targeting novel pathogenic pathways are urgently needed to achieve
sustained remission. Our preliminary data indicate that HHi resistance is associated with dysregulation of BRD7
and BRD9, which are part of the SWItch/Sucrose Nonfermentable (SWI/SNF) chromatin remodeling complexes,
and that tumoral BRD9 signaling promotes an immunosuppressive tumor microenvironment (TME). The
proposed studies aim to elucidate BRD9-mediated immune suppression as a mechanism of HHi resistance.
Utilizing CRISPR/Cas9-edited BRD9 knockout and BRD9-overexpressing BCC cells, along with
BRD7KO/Ptch1+/- mice that develop HHi-resistant BCCs in response to UV exposure, Aim 1 will explore BRD9
regulation of chemokines and comprehensively define immune cell compositions and their functional states
underlying HHi resistance. Aim 2 will determine the preclinical efficacy of combined targeting of BRD9 and
immune checkpoints and test the hypothesis that BRD9 blockade potentiates anti-tumor immunity.

Public health relevance
NARRATIVE Clinical resistance and tumor recurrence are major limitations of currently available targeted therapies for patients with basal cell nevus syndrome (BCNS), as well as for patients with sporadic BCCs that are surgically inoperable or have metastasized. We will investigate the BRD7-BRD9 axis-driven immune suppression as a mechanism of BCC resistance and test the preclinical efficacy of BRD9 blockade in potentiating the antitumor immune response.